Mechanistic insight into the regulation of the apical bile acid transporter (ASBT) using chemical biology approaches

The proposed research is relevant to public health due to the essential role of bile acids in the regulation of lipid
and glucose metabolism. Identification of mechanisms that modulate the stability of the human apical bile acid
transporter may facilitate the development of innovative therapeutic strategies to restore bile acid flux and
signaling in humans.